Assessing the Feasibility of Economic Approaches to Prevention of Substance Abuse among Adolescents

PROJECT ABSTRACT
Adolescent alcohol and drug use (ADU) is a significant public health challenge in sub-Saharan Africa (SSA).
About 41.6% of adolescents in SSA reported using at least one psychoactive agent, with alcohol being the most
commonly used drug. Uganda, one of the poorest countries in SSA, has the second highest rate of per capita
alcohol consumption in SSA (15.1 liters of pure alcohol vs regional average of 6.2 liters of pure alcohol) and over
one third of Ugandan adolescents have used alcohol in their lifetime, 22.5 million are current drinkers, and over
50% engage in heavy episodic drinking. These estimates reach even greater magnitudes in the country’s fishing
villages – a key HIV vulnerable population- where ADU is normative. A few studies have assessed ADU among
AYLHIV, yet AYLHIV are at higher risk for ADU, and ADU impedes adherence to anti-retroviral therapy (ART),
retention in care, and viral suppression. Several studies have examined the risk and resilience factors for ADU
but few interventions targeting ADU have been tested in SSA. Only 10 ADU interventions have been evaluated
in SSA and only a few have been successful. The majority have been implemented in school settings, which
may exclude adolescents in fishing communities that have high rates of school dropout. Moreover, none has
targeted risk factors such as poverty and mental health, which are rampant among AYLHIV and their families,
undermine AYLHIV’s coping skills and resources, and have been associated with increased risk for ADU among
adolescents. Family-based economic empowerment (FEE) interventions have the potential to prevent ADU
among AYLHIV by reducing poverty and its associated mental health impacts, and also bolstering AYLHIV and
their families’ resources to overcome the challenges associated with HIV. Given the lack of evidence-based
culturally tailored interventions to prevent ADU in AYLHIV in low-income settings such as Uganda, this study
proposes to: Aim 1a. Examine the prevalence and consequences of ADU in a sample of 200 AYLHIV (ages 15-
24) seen at six (6) HIV clinics located in the fishing communities of southwestern Uganda. ADU will be measured
using self-report and biological data (i.e. urine). Aim 1b. Using a mixed methods approach, identify the multi-
level (individual, interpersonal, community and structural) factors associated with ADU among AYLHIV. Aim 2:
Using a subset of the sample, explore the feasibility and short-term effects of a FEE intervention on ADU among
AYLHIV. Our intervention focuses on older adolescents and young adults in a high-risk environment (i.e. fishing
communities) to elucidate the contextually relevant risk and resilience factors for ADU among AYLHIV
undergoing social transitions. Additionally we innovatively target the most commonly occurring risk factors for
ADU (i.e. poverty and mental health problems) through the FEE that includes provision of youth development
savings accounts, financial literacy sessions and ADU risk reduction sessions. Our findings will inform the design
of an R01 grant to examine the long-term effects of a family-based economic empowerment intervention on ADU
among AYLHIV.

Public health relevance
PROJECT NARRATIVE The proposed study will be the first to innovatively examine the impact of family-based economic empowerment intervention on reducing alcohol and drug use (ADU) among adolescents and youth living with HIV (AYLHIV) in poverty-impacted communities in Uganda, and focuses on improving understanding of multi-level context- specific risk and protective factors for ADU among AYLHIV. Given that many ADU interventions evaluated in sub-Saharan Africa have not been successful, study findings could inform interventions to reduce/prevent ADU, and also improve our understanding of the epidemiology, risk and resilience factors and consequences of ADU among AYLHIV, in order to inform the development of effective ADU prevention intervention. Lessons learned from implementing ADU prevention efforts in low-income countries such as Uganda, may be relevant to improving overall care for other vulnerable adolescent populations in sub-Sahara Africa where the burden of ADU is increasing yet strategies to alleviate the burden of ADU among young people at high risk are lacking.